PAtient-centered mUltidiSciplinary care for vEterans undergoing surgery (PAUSE): a hybrid 1 clinical effectiveness-implementation intervention trial

The long-term goal of this project is to improve Veteran health and longevity by developing and
implementing an evidence-based screening strategy to prevent death from second primary lung
cancer (SPLC) in lung cancer survivors. This is important because SPLC is distinct from
recurrence and is one of the main mortality risks for survivors. Despite its importance, there is
no evidence-based standard-of-care for basic questions like which patients to screen for SPLC
and for how long. As treatment and screening improve and the number of lung cancer survivors
increase, there is a critical need for research into interventions to implement evidence-based
cancer screening for cancer survivors. To address this need, we propose to adopt an evidence-
based strategy increasingly used in initial primary lung cancer (IPLC) screening, risk
stratification. Risk stratification has led to marked improvements in IPLC screening, increasing
screening efficiency while also containing ballooning healthcare costs and reducing disparities.
To achieve similar improvements for SPLC, our group has developed and validated a predictive
model to stratify lung cancer survivors by risk of SPLC, now to be piloted in a clinical setting in
this project. Our project is innovative as it is the first (to our knowledge) to implement risk
stratification for SPLC. The objective of our proposal is to develop a Veteran-specific and
disparity-sensitive clinical decision support tool to stratify Veterans by SPLC risk in clinic. Our
central hypotheses are that 1) our model can accurately identify Veterans at high risk for SPLC
and 2) identification of high-risk patients is feasible in a VA clinical setting. To accomplish the
study objective, the following specific aims will be pursued. Aim 1 will validate and adapt our
previously developed SPLC risk prediction model for Veterans, utilizing patient demographics,
smoking history, and IPLC treatment, stage and histology derived from the VA EMR. Aim 2 will
identify factors that influence feasibility and acceptability of a SPLC risk stratification tool, using
a mixed methods approach to focus on provider decision-making and structural or systemic
influences at the facility level. Aim 3 will translate the SPLC risk prediction model into a clinical
decision support tool and pilot the tool at a single VA site, using iterative cycles to improve tool
uptake. Following successful completion of this proposal, the expected research outcomes are
to have 1) an updated optimal SPLC risk prediction model for Veterans and 2) a feasible clinical
decision support tool based on the model, which a clinician can use to identify patients at high
risk of SPLC. In addition, the mentored training program described in this proposal will
accelerate Dr. Julie Wu’s development into an independent health services researcher. Her
mentorship team includes Drs. Arya, Backhus, and Han- leaders in implementation science,
thoracic oncology, and predictive modeling. From this proposal, the expected training outcomes
will be 1) training in advanced modeling and database analytics and 2) training in qualitative
methods and implementation science, which will help the PI achieve her research career goal of
bridging the implementation gap between evidence and practice. Moreover, by completing this
project, Dr. Wu will establish the training foundation and preliminary data for a CDA-2
application to identify current barriers to screening in high-risk Veteran lung cancer survivors
and pilot an intervention aimed at overcoming those barriers. This project will have impact as
Dr. Wu is part of the VA National Oncology Program and thus uniquely positioned to guide
future expansion of the SPLC screening program across the national VA network.

Public health relevance
Improving lung cancer survivorship care is critical to Veteran health. Each year, 7700 Veterans are diagnosed with lung cancer. With advances in treatment and screening, the number of Veteran survivors of lung cancer are expected to increase. However, lung cancer survivors are at increased risk of dying from a second primary lung cancer. The proposed research will prevent death of Veteran lung cancer survivors by improving screening practices for second primary lung cancer. To do so, it will use predictive models tailored specifically to the unique cancer risk profiles of Veterans, achieved by using Veteran data. This project to prioritize screening to identify early-stage lung cancer in high-risk Veterans by putting VA data to work for Veterans intersects the missions of the VA National Precision Oncology Program and VA Health Services Research and Development Service.